Developing a Hive Learning and Datathon Supported Course on Imaging and Multimodal Data for Resource-Limited Institutions (CIMDAR-HIVE)

ABSTRACT
AI tools such as deep learning models promise significant improvements in healthcare efficiency, accuracy, and
fairness. However, without careful development, these systems might unintentionally exacerbate healthcare
disparities. Subtle variations in medical imaging, influenced by factors like a patient's race, gender, or insurance
status, may be imperceptible to humans but can be leveraged by AI algorithms, potentially leading to biased
predictions.
This project seeks to uncover hidden signals in AI models and evaluate their potential effects on fairness. We
will utilize three extensive medical imaging datasets from Emory University, encompassing a variety of patient
populations and outcomes. Using advanced generative techniques, we will generate synthetic counterparts of
these datasets based on demographics, social factors, and clinical variables. Deep learning models will then be
trained on both real and synthetic images to predict sociodemographic factors and measure the persistence of
hidden signals across data types. By exposing models to manipulated synthetic data, we aim to identify potential
unfair associations undetectable in actual patient data. Additionally, we will condense images into mathematical
representations and conduct predictive experiments to ascertain if shortcuts are present. Radiologists will
analyze simulated videos transitioning images between demographic groups to visualize results and determine
if these shortcuts hold clinical relevance. Our objective is to develop tools and guidelines fostering the creation
of reliable AI systems in medical imaging to enhance patient outcomes across all groups.
Overall, this project combines innovative data generation, predictive modeling, and human-AI collaborative
evaluation to proactively identify and mitigate unfair bias in healthcare AI. Our findings will help prevent AI from
perpetuating disparities and ensure it fulfills its potential to provide equitable quality care for diverse populations.

Public health relevance
PROJECT NARRATIVE Our education program, CIMDAR-HIVE, is designed to revolutionize health data science education and research, particularly for early-career researchers, postdocs, and faculty from resource-limited institutions (RLIs). The program incorporates a one-week, in-person course that combines hive learning and datathon principles to provide participants with practical experience handling multimodal datasets, as well as the necessary skills to navigate cloud computing, AI ethics, and collaborative science. This initiative, utilizing the NIH common fund Bridge2AI CHORUS and DSI-Africa MUDSReH datasets, aims to democratize data science education, address health disparities through diverse research, and equip attendees to innovate in the biomedical field.